CRCNS: Deconstructing Dynamics of Motor Cortex in Freely Moving Behavior

PROJECT SUMMARY (See instructions):
What operations are performed by the mammalian central nervous systems to coordinate and conduct
voluntary movement? Motor systems neuroscience seeks to understand these neural mechanisms. The
last two decades have witnessed a transformation in this field with the use of multielectrode recordings
and statistical estimation and modeling techniques. These technological advances have yielded rich,
low-dimensional neural dynamics that are suggestive of the mechanisms underlying behavior. To
minimize confounds, the overwhelming majority of these studies utilize behavioral constraint to isolate just
the behaviors of interest for study. While effective for generating many behaviorally similar trials, this may
have the unintentional consequence of artificially constraining neural dynamics to a subset of its full
range.
This project seeks to better understand the full repertoire of behavior in a freely-moving setting and model
this neural activity using novel computational tools. This project combines the expertise of two
neuroscientists with complemenary skillsets spanning systems and computational neuroscience. This
project will involve acquiring novel, freely-moving data using the recent advances in depth imaging
cameras and modeling the dynamics of the labelled neural data with innovative switching dynamical
models.
TThis combined expertise will be applied to the investigation of the initiation vs sustaining of movement,
the decomposition of walking periods into distinct dynamical regimes, and an analysis of foraging
behavior.
Taken together, these studies will further our understanding of how neural dynamics drive unconstrained
motor behavior. This insight has implications for the development of ambulatory brain-machine interfaces
and may inform the treatment of individuals with motor disorders such as stroke.

Public health relevance
Among all organs in the body, we understand the brain least--we still do not know how the brain controls movement. This work seeks to uncover explanations on how the brain controls voluntary movement in free behavior like walking and running. This new insight will be critical to developing better recovery treatments for people with movement disabilities.